Harvard University Center for AIDS Research

PROJECT SUMMARY/ABSTRACT: Overall
This application proposes continued funding of the Harvard University Center for AIDS Research (HU CFAR).
The HU CFAR is the umbrella and coordinating organization for all HIV research at Harvard, operating out of
the Harvard University Provost’s Office. The HU CFAR serves to integrate HIV research across Harvard
affiliated schools, such as Harvard Medical School and the Harvard TH Chan School of Public Health, as well
as Harvard-affiliated hospitals and institutes, including Dana-Farber Cancer Institute, Beth Israel Deaconess
Medical Center, Boston Children’s Hospital, Massachusetts General Hospital, Brigham & Women’s Hospital,
Ragon Institute of Mass General, MIT and Harvard, and Fenway Health. The HU CFAR also has strong
collaborations with the Massachusetts Department of Public Health, Boston Public Health Commission and
community-based organizations and with global sites, extending its reach to additional key clinical populations
and research sites outside Harvard. The HU CFAR leverages strong institutional support to promote
multidisciplinary HIV research through its Cores, Scientific Working Groups and Scientific Programs. The HU
CFAR includes an Advanced Laboratory Technologies Core, a Biostatistics and Bioinformatics Core, a Bio-
Behavioral and Community Science Core, and a Clinical Core. In addition, the HU CFAR Developmental and
Mentoring Core supports innovative pilot projects and provides mentorship to develop the next generation of
HIV researchers. These Cores are supported by the HU CFAR Administrative Core, which provides
administrative support and fiscal oversight and oversees strategic planning. Based on an inclusive strategic
planning process, the HU CFAR has also formed steering committees to promote basic and translational
science and research on ending the HIV epidemic as well as integration of diversity, equity and inclusion
throughout all aspects of the CFAR. Briefly, we propose to:
1. Support innovative, multidisciplinary research initiatives addressing key HIV-related research priorities
aimed at mitigating the effects of infection and bringing an end to the epidemic.
2. Engage, support and mentor the next generation of early career investigators in HIV research.
3. Promote Diversity, Equity and Inclusion (DEI) throughout all aspects of the CFAR and expand
Community Engaged Research.
4. Facilitate and expand synergistic multidisciplinary collaborations among Harvard-affiliated HIV
researchers and their trainees through innovative leadership, scientific planning and management.

Public health relevance
PROJECT NARRATIVE: Overall The Harvard University CFAR (HU CFAR) provides the infrastructure to coordinate, support and add value to Harvard investigators’ cutting-edge multidisciplinary HIV research programs and to forge new collaborations and synergies. The HU CFAR pursues innovative initiatives to address critical HIV-related research priorities and train the next generation of HIV researchers. By leveraging the exceptional strengths of Harvard and its institutional support, the HU CFAR promises to continue to provide major leadership in the global effort to prevent and treat HIV.